Measuring and Mapping Trajectories of Risk and Resilience for Suicidal Thoughts and Behaviors in Sexual Minority Preteens

PROJECT SUMMARY/ABSTRACT
Today’s sexual minority (SM) youth are coming out at increasingly younger ages, with the average age of
disclosure at 13 years old and 35% coming out as preteens. SM preteens experience up to 6 times higher risk
for suicidal thoughts and behaviors (STBs) compared with their heterosexual peers. SM preteens’ social and
developmental contexts likely contribute to significant risk and protective factors for STBs. For example, they
must simultaneously navigate preteen developmental stressors and supports (like peer relationships and first
romantic experiences) while also managing an emerging SM identity and associated exposure to stigmarelated
stress and resilience. Yet, several knowledge gaps remain. The field of SM preteen research is in its
infancy, without consensus on best practices for sampling and recruiting high-risk SM preteens. The field also
lacks psychometrically valid assessments for SM preteens as well as longitudinal studies assessing risk and
resilience trajectories during this sensitive developmental period. The overarching goal of this rigorous multimethod
project is to address these gaps. Youth and parent advisory boards will be assembled to enrich our
research and ensure its cultural responsiveness, ethical soundness, and ultimate benefit to SM preteens and
families. Our research will address three aims. First, we will use a five-step Delphi process to develop
consensus among a diverse panel of experts (including researchers, clinicians, legal experts, parents, leaders
of SM community youth groups) on best practices for safely, ethically, and effectively sampling, recruiting, and
retaining SM preteens at risk for suicide into research. Second, we will create and pretest an assessment of
stigma-related stress and resilience for SM preteens using a three-phase approach (developing an initial item
pool; refining items; establishing content validity with SM preteens). Last, we will enroll a national cohort of
preteens at risk for suicide with one parent/caregiver, which we will call the SPARK (SM Preteens Advancing
ouR Knowledge) Cohort. SPARK participants will be administered an online assessment battery of SM status,
developmental stressors and supports, stigma-related stress and resilience, and STBs every 6 months for 2
years. Analyses will use rigorous weighted generalized estimating equations to estimate trajectories of risk and
protective factors for STBs. Subgroup analyses will examine how trajectories of STBs and associated risk and
protective factors differ by sexual minority status as well as race and ethnicity and other theoretically informed
intersectional factors among preteens. This research is guided by an innovative conceptual model integrating
advances in developmental science with the NIMHD Health Disparities Framework and involves community
partners at SM youth organizations nationwide to enhance feasibility. Findings from this project will advance
best practices for sampling SM preteens, measuring stigma-related stress and resilience, and mapping
trajectories of risk and protective factors for STBs, aligning with key NIMH priorities.

Public health relevance
PROJECT NARRATIVE Preteen suicide is a growing public health crisis, and the substantially greater risk for suicidal thoughts and behaviors reported among sexual minority (SM) preteens is concerning. Consistent with NIMH programmatic priorities, this project will deploy an innovative mixed-methods approach incorporating advisory board and expert feedback, measurement development, and longitudinal data collection and analysis to study risk and protective factors for suicide in SM preteens. Given the disproportionate risk for suicide among SM preteens and the dearth of prospective research involving this high-risk population, this project represents a novel scientific advancement to inform suicide prevention.